Determining the nigrostriatal circuit basis of false auditory perceptions.

Project Summary/Abstract
Auditory perception can become disrupted in disorders like autism and psychosis. Higher-order auditory pro-
cessing occurs in the auditory thalamus and cortex. In turn, these areas project to the tail of the striatum (TS),
where dopamine has been shown to modulate auditory processing and sound-guided decision-making. Given
that dopamine transmission is disrupted in a wide range of neurological and psychiatric disorders that present
with perceptual deficits, it is important to better understand the dopamine system's role in these deficits.
Inhibiting dopamine projections to the TS has been shown to disrupt auditory discrimination, and activat-
ing these projections induces false auditory perception in mice. Our group has shown that decreases and in-
creases in dopamine transmission unbalance the activity levels of the striatum's principal output neurons: the
D1- and D2-dopamine receptor-expressing spiny projection neurons (SPNs). The goal of this proposal is to un-
derstand how excess dopamine causes false auditory perception and which striatal sub-regions and SPN types
mediate these effects. To do this, we will use viral- and mouse-genetic approaches to selectively activate specific
dopamine projections and record striatal dopamine transmission and D1- or D2-SPN Ca2+ activity. We will com-
bine these tools with a recently established behavior for measuring auditory perception confidence (APC) in
mice. Specifically, we will (1) determine the effects of selectively activating dopamine projections to the TS or
dorsomedial striatum (DMS) to determine whether these two pathways differentially modulate the frequency
and/or confidence of false auditory perceptions. Next (2) we will use miniature microscopes to image Ca2+ activity
in striatal D1- and D2-SPNs activity under normal conditions and while selectively activating nigrostriatal dopa-
mine projections during the APC task. Finally (3) we ask whether we can attenuate dopamine-driven false per-
ceptions by chemogenetically manipulating D1-SPNs vs. D2-SPNs during the APC task.
By detailing how specific dopamine sub-circuits influence auditory perception, our experiments will inform
both the basic sensory and translational neuroscience fields. The work builds upon recent work from our labor-
atory and has the potential to unveil new therapeutic strategies for diseases with prevalent sensory deficits like
psychosis and autism. The fellowship ensures that I master the techniques associated with this proposal and
receive world-class training in in vivo imaging and genetic targeting techniques, coding and data analysis, sci-
entific communication, teaching and mentorship, and further knowledge of the basal ganglia and its implications
in disease. My training plan also entails scientific outreach in the greater Chicago area and mentorship of under-
graduate trainees. These activities are anchored by a strong co-mentorship team (Drs. Jones Parker and Raj
Awatramani) and a vibrant research and academic environment at Northwestern University.

Public health relevance
Project Narrative Deficits in sensory processing are common in brain disorders, but the neural substrates of these deficits are poorly understood, and the treatments for them are limited. Evidence suggests that higher-order auditory processing is subject to modulation by dopamine signaling in the striatum—a process that may go awry in diseases like schizophrenia. The current study will combine genetic circuit manipulations with in vivo imaging and behavior to link activity in specific dopamine projections and the modulation of specific striatal neuron types to auditory perception deficits that may be relevant to psychiatric disease.